Seattle-Denver Center of Innovation for Veteran-Centered and Value-Driven Care

The dual site Center of Innovation (COIN) for Veteran-Centered and Value-Driven Care is located at the
VA Puget Sound and Eastern Colorado Health Care Systems. Research products from our Center's 47
investigators have impacted VA policy and care delivery across a spectrum of primary, specialty and mental
healthcare services. We accomplished these impacts through partnerships with operational leaders and
application of the National Academy of Medicine's Learning Health System (LHS). We employ the LHS through
our research, implementation science, evaluation and training programs. Collectively, we help the VA become
an efficient healthcare system where best practices and new knowledge are translated into clinical care.
Our mission is to conduct high-quality health services research that promotes Veteran-centered and value-
driven care, generate and disseminate knowledge that contributes to the well-being of Veterans, work
collaboratively with VA policy and operational leaders to implement research finding into clinical care, and train
the next generation of health services research leaders.
In the next 5 years, we will continue to align our programs with challenges faced by patients, providers, and the
VA health system. We have 2 research focus areas with 3 objectives embedded within each:
1. Promote Veteran-centered care and improve the patient experience across VA healthcare and
community settings. We will accomplish the following: 1) develop methods to incorporate patient reported
outcomes into routine clinical care and test interventions to improve these outcomes, 2) improve patient
adherence and self-management through interventions targeting patients, providers and health systems, 3)
innovate the delivery of specialty, mental, and/or primary health care services to patients using patient-
centered approaches that bridge socioeconomic and geographic disparities.
2. Advance value-driven care by providing Veterans the highest quality care at lowest financial burden. We
will develop new approaches to care that: 1) help the VA efficiently utilize, integrate, and coordinate health
services received within the VA and in the community, 2) improve the quality and safety of care through
appropriate implementation and de-implementation of healthcare services and 3) identify methods to
improve workforce development, deployment, and provider satisfaction and well-being.
Our emerging research areas include women's health, suicide prevention, and eliminating disparities. We have
led and will continue to lead Veteran engagement efforts in research for VA nationally.
Over the past 3 years, we obtained funding for 113 projects, generated $47 million in operating revenue and
published 583 manuscripts. We trained 35 post-doctoral fellows and 12 VA and non-VA career development
awardees. Our investigators were awarded the HSR&D best paper awards in 2015 and 2016. Our work has
been recognized by national media, presented to Congress, resulted in legislation, designated as VA promising
practices for broad dissemination, and informed both VA-wide health services improvements and CMS policy.
Drs. David Au (in Seattle) and P. Michael Ho (in Denver) will continue as co-Directors along with Associate
Directors, Drs. Steven Zeliadt (Seattle) and Cari Levy (Denver). Collectively, they have worked together for
more than 10 years, are outstanding researchers and have experience leading complex organizations.
Our Center excels in engaging operational partners including the Offices of Patient-Centered Care and Cultural
Transformation; Rural Health; Primary Care; Specialty Care; and Veterans Access to Care. Research products
strategically address VA operational and VA Secretary priorities. We work closely with the Universities of
Washington and Colorado, where all our investigators serve as faculty. Further, we have strong ties with our
respective medical centers, VISNs, and partners outside VA including NIH, CDC, and Kaiser Permanente.

Public health relevance
The Center of Innovation (COIN) for Veteran-Centered and Value-Driven Care has had outstanding productivity and impact on Veteran healthcare and well-being through the application of the National Academy of Medicine's learning health system. In the past 3 years, our 47 investigators generated ~$47 million in operating revenue, published 583 manuscripts, and led 113 projects across our research, implementation science, operational projects/program evaluations and training programs. Our dual-site Center will continue to address our two focus areas: 1) promote Veteran-centered care to improve patient experiences across VA healthcare and community settings and 2) advanced value-driven care by providing Veterans the highest quality care at the lowest financial burden. Building on our prior success, we will continue to partner with operational leaders and our Veteran Engagement Board to innovate new research, implementation science, and operational programs as well as train the next generation of outstanding research leaders.